FGFR3 Activities in the Control of Skeletal Growth

PROJECT SUMMARY
Skeletal growth occurs during development in cartilage growth plates, bone template regions wherein
chondrocytes actively proliferate, follow a stepwise maturation program, and produce an abundant extracellular
matrix. Their activities are tightly regulated by numerous factors, including the fibroblast growth factor receptor-
3 (FGFR3), whose importance in humans is illustrated by the fact that FGFR3 gain-of-function variants
(FGFR3Ach) cause achondroplasia (ACH), the most frequent form of short stature. The disorder markedly affects
the appendicular skeleton (short limbs), axial skeleton (vertebral stenosis and lordosis) and craniofacial skeleton
(frontal bossing and flat face) and also results in a large spectrum of neurologic issues. Various types of surgical
and pharmacological treatments have been proposed and approved for this condition, but none addresses all
clinical issues, and long-term outcomes are unknown. There is thus an urgent clinical need to develop new, safe
and efficient treatments for ACH. We propose to help address this need by deepening our current understanding
of the pathways acting upstream and downstream of FGFR3 in growth plate chondrocytes (GPCs) and by testing
in preclinical models if targeting newly identified pathways may provide successful treatments. Aim 1 will test the
hypothesis that the expression of FGFR3 is controlled by several cis-acting regulatory elements (CREs) and that
the inactivation of key CREs could safely and effectively lessen the severity of ACH. This hypothesis and our
research strategy rely on a solid scientific premise constituted by published and pilot data. We will create and
analyze CRE reporter transgenic mice to determine to which extent individual CREs reproduce the expression
pattern of Fgfr3. We will also determine which CREs most significantly contribute to Fgfr3 expression in mice by
deleting the most likely ones in the Fgfr3 wild-type and ACH alleles and assessing phenotypic consequences.
Aim 2 will test the hypothesis that FGFR3Ach perturbs a pathway critical to ensure the high-energy demands of
GPC activities and whose link to FGFR3Ach was uncovered in pilot studies. We will analyze to which extent this
pathway is perturbed and affects GPC activities in ACH. Further, we will use transgenic approaches to test if
normalizing this pathway may safely and effectively lessen ACH features. This project is highly significant and
innovative considering on the one hand the prevalence and severity of ACH and the current lack of fully satisfying
treatments, and considering on the other hand that it will push forward the frontiers of scientific knowledge to
propose novel, potentially life-changing strategies to treat people with ACH, and may also suggest novel
mechanisms and treatments for other chondrodysplasias and still poorly treatable FGFR3-related cancers.

Public health relevance
PROJECT NARRATIVE Achondroplasia, the most common form of short stature in humans, is due to variants in FGFR3 that over- activate the fibroblast growth factor receptor 3 and thereby severely impair the specific activities of cartilage growth plate cells. This project is designed to increase current knowledge of the mechanisms controlling FGFR3 expression in these cells and affecting them downstream of FGFR3 in achondroplasia. The ultimate goal is to propose novel strategies, whereby the targeting of these mechanisms would provide direly needed, safe and effective treatments for people with achondroplasia and related conditions.